Structure and Interactions of Conformational Intermediates in gamma-D Crystallin Aggregation, and Their Targeting for Cataract Prevention

PROJECT ABSTRACT
Cataracts result from progressive aggregation of eye lens crystallin proteins. Severity of age-onset cataract has
been linked to specific post-translational modifications in crystallins that accumulate during aging. Two important
classes of cataract-associated modifications are oxidation of Trp residues to more hydrophilic products and
oxidation of Cys residues to generate disulfide bonds. Our prior research has revealed a crucial synergy between
the two. The W42Q variant of human γD crystallin (a Trp oxidation mimic) and the W42R congenital-cataract
variant, are destabilized but well folded and soluble under reducing conditions, yet formation of a non-native
internal disulfide bond (Cys32-Cys41) kinetically traps them in a partially unfolded conformational intermediate,
generating rapid and robust aggregation at physiologically relevant temperature, pH, and concentration in vitro.
We have developed a rapid, atomistic Monte-Carlo modeling method, with a knowledge-based statistical
potential, that is uniquely suited for the study of conformational intermediates, including in multiple polypeptide
chains as they simultaneously unfold to reveal new protein-protein interactions. We have already applied this
method to γD crystallin and its variants to predict not only the structure of the aggregation-prone intermediate
but also, for the first time, an atomistic model of the aggregated state. Experimentally, we recently discovered a
novel oxidoreductase activity in human γD crystallin and demonstrated that native-state disulfides in WT can be
transferred to generate the non-native, aggregation-promoting disulfide in W42Q. We found an even more
surprising WT/mutant interaction – domain interface stealing – that allows WT to catalyze mutants’ aggregation
even in the presence of an abundant external disulfide source. We will now (1) investigate the physical principles,
kinetics, and evolutionary and disease implications of the novel interface stealing interaction by a combined
computational, biochemical, and proteolysis/mass spectrometry approach we are now developing; and (2)
distinguish among atomistic models for the aggregation precursor and the aggregated state and (3) apply these
newly refined atomistic models to rationally design structure-based peptide inhibitors of the aggregation process.
Although our studies have focused on the W42Q/R variants, other cataract-associated variants (V75D, L5S)
appear to behave quite similarly. Moreover, both the native and the non-native disulfide we identified as culprits
in aggregation processes have been entirely supported by tissue proteomics of aged and cataractous human
lenses in the absence of any genetic mutation. We will therefore test the hypothesis that many mutations or post-
translational modifications converge on few conformational intermediates that determine aggregation. We will
generalize the detailed mechanistic and structural picture of aggregation to other γ-crystallins and other cataract-
associated variants testing whether human γC and γS crystallins are also redox-active and capable of interface
stealing. A more general understanding of the synergy between structural destabilization and redox chemistry in
cataract will improve design of aggregation inhibitors testable on existing genetic mouse models of cataract.

Public health relevance
PROJECT NARRATIVE As the population ages, cataract lowers vision of millions of Americans every year, requiring costly surgery, and it leads to blindness for millions of others in the developing world where surgery is unaffordable. We have found evidence that cataracts arise from the combination of irreversible destabilizing modifications, reversible oxidative modifications (disulfide bonds), and an unusual “interface stealing” interaction between eye lens crystallin proteins, which together lead to aggregation of these proteins. We will study the biochemical mechanisms and the altered protein structures that underlie this aggregation process and apply this combined knowledge to design aggregation inhibitors that could prevent or delay cataract.